Pathogenic Mechanisms of Inflammatory Subventricular Zone Injury in Preterm Infants

ABSTRACT:
Preterm birth is the leading cause of life-long neurodevelopmental impairment (NDI) in infants. Common
complications of prematurity such as intestinal perforation confer a significant risk for diffuse myelination deficits
and NDI. Diffuse hypomyelination can reliably detected after affected infants reach term corrected ages however,
this is often months after the intestinal perforation has occurred. Using our mouse neonatal modeled intestinal
perforation (MIP) model, we discovered a previously unrecognized injury to the multiciliated ependymal cell layer
that forms the ventricular border of the subventricular zone (SVZ) neural stem cell niche. The functional role the
multiciliated ependyma extends beyond controlling CSF flow and barrier formation but is known to involve the
regulation of SVZ progenitor populations within the niche. In our MIP model, disruption of the ependyma was
associated with increased echogenicity on cranial ultrasound. Our animal research led us to interrogate the SVZ
and germinal matrix of preterm infants using cranial ultrasound following intestinal perforation leading to the
novel discovery that a subset (~40%) of preterm infants develop subventricular zone echogenicity (SVE) as early
as 48 hours after intestinal perforation. Importantly, the development of SVE was a predictor of NDI on the 2-
year Bayley test suggesting that SVZ injury is an early mechanism of brain injury and NDI in human preterm
infants. Our preliminary data comprising of both single cell and spatial transcriptomic approaches, support the
hypothesis that NFkB-enriched IL-1b producing peripheral monocytes traffic onto the ependymal surface of the
lateral ventricles via the choroid plexus where they seed the surface of the SVZ. Our preliminary data identified
a unique role for IL-1b at disrupting ependymal cell survival relative to TNFa or IL-6. Our preliminary data also
revealed that the LXR agonist, 20-aHydroxychoelsterol, suppresses NFkB signaling and IL-1b production in the
monocyte/macrophage lineage and appears to prevent MIP-induced SVZ injury. Our central hypothesis is that
blood-born monocytes infiltrate the SVZ and increase localized IL-1b production leading to the disruption of the
ependymal barrier and collapse of this critical stem cell niche’s functions. Aim 1 will use scavenged blood
samples from preterm infants with intestinal perforation to define immune signatures associated with the
development of SVE using a scRNAseq approach. Aim 2 will define immune signatures that are associated with
murine SVE and compare our findings to the human data generated in Aim 1. We will also investigate the role
of monocyte/macrophage accumulation in the choroid plexus and their role in SVZ injury. Aim 3 will utilize
genetic approaches to interrogate the specific role of monocytic-derived IL-1b on SVZ injury and determine if
20HC is a viable therapeutic approach to brain injury in preterm infants.

Public health relevance
Project Narrative: Preterm birth is highly associated with intestinal complications that are linked to brain injury and life-long neurologic impairment. This project will analyze immune responses in both preterm infants and animal models of disease to understand the inﬂammatory mechanisms linking intestinal complications and preterm brain injury.